Targeting Interleukin-17 inflammatory Axis in CTEPH

ABSTRACT
Chronic thromboembolic pulmonary hypertension (CTEPH) is a deadly sequela following acute pulmonary em-
bolism (PE). In CTEPH, the acute PE does not resorb but develops into organized “thrombi,” causing pulmo-
nary vascular remodeling, leading to progressive right heart failure and death. The gold standard treatment for
CTEPH is surgery, but many patients are not surgical candidates due to comorbidities or surgically inaccessi-
ble disease. For these patients, there are only limited options that have only been shown to improve short-term
symptoms. Thus, developing novel medical therapies for CTEPH is a significant unmet need. Drug develop-
ment has been limited by the significant knowledge gap on how different cell types and signaling pathways
within chronic thrombus contribute to pulmonary vascular remodeling and pulmonary hypertension (PH). This
puts into context our preliminary studies, using single-cell RNA sequencing (scRNAseq) and ex-vivo culturing
of patient thrombus-derived cells, we identified upregulated inflammatory and proliferative signaling pathways
that may contribute to chronic thrombus development and pulmonary vascular remodeling. We showed that a
phenotypically-modulated smooth muscle cell (SMC) population expresses a high level of PAR1, a receptor
that promotes SMC proliferation and migration and propagates IL-17-mediated inflammation. Our data also
revealed that SMCs, macrophages, and T cells are enriched for IL-17 signaling, which has been implicated in
numerous inflammatory diseases and promotes venous and arterial thrombosis, suggesting a role for the
PAR1/IL-17 signaling axis in CTEPH pathogenesis. Thus, our central hypothesis is that the PAR1/IL-17 sig-
nal axis propagates abnormal chronic thrombus development and pulmonary vascular remodeling in CTEPH,
linking inflammation and pulmonary vascular remodeling in this disease. The overall objective of this applica-
tion is to determine the contribution of PAR1/IL-17 signals to the development of abnormal cellular phenotypes
in chronic thrombus, initiation, and progression of CTEPH using human samples and animal models. Aim 1 will
determine if the PAR1/IL-17 signaling synergistically promotes abnormal thrombus-derived mesenchymal cell
phenotypes. In Aim 2, we will evaluate the activity of the PAR1 and IL-17 signaling axes in different immune
and mesenchymal cells in human CTEPH using flow cytometry and single-cell technologies. In Aim 3, we will
determine whether inhibiting the PAR1/IL-17 signaling axis prevents and reverses CTEPH in vivo using a ro-
bust small animal model of CTEPH that we have developed. The rationale for these studies is that defining the
mechanisms contributing to inflammation and proliferation will aid the development of novel CTEPH medical
therapies. The expected outcome of this project will be to determine whether the PAR1/IL-17 signaling axis
promotes disease progression in CTEPH and could serve as a disease target. This will lay the groundwork for
future studies on novel CTEPH treatments targeting SMC and immune cell activation. These studies will have
a significant positive impact as they will aid in developing new CTEPH therapies.

Public health relevance
PUBLIC HEALTH RELEVANCE Our research seeks to understand the basis for developing chronic blood clots in the lungs and how this knowledge could be used to treat chronic blood clots with new medical therapies. The proposed research is relevant to public health because 200,000 people in the United States have a blood clot in their lungs each year, and ~ 5% of them will develop a chronic blood clot. Thus, the proposed research supports the NIH’s mission to develop fundamental knowledge and application of that knowledge to enhance health and reduce illness.